IGF::OT::IGF - RTI INTERNATIONAL TO PROVIDE SUPPORT SERVICES FOR FUNCTIONAL AREA TWO (2) OF THE NHLBI INNOVATION AND COMMERCIALIZATION COORDINATING CENTER (NIC3) FOR A PERIOD OF PERFORMANCE OF MAY 1,

SUPPORT SERVICES FOR FUNCTIONAL AREA TWO (2) OF THE NHLBI INNOVATION AND COMMERCIALIZATION COORDINATING CENTER (NIC3)